2025 Carotenoids Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
The Carotenoids GRC is an international scientific conference focused on presentation of cutting-edge and
unpublished research, scholarly discussion, and informal interactions among scientists of all career stages.
Carotenoids are widespread isoprenoid pigments, vital for photosynthetic organisms and human health. In
addition, they are the precursor of retinoids, such as vitamin A, and plant growth regulators and hormones
involved in almost all aspects of plant life, including growth, development, stress response and communication
with biotic environment. Animals obtain carotenoids through the diet and can accumulate, modify and convert
them into retinoids and other bioactive apocarotenoids. Humans obtain carotenoids from red, orange, yellow,
and dark green fruits and vegetables (F&Vs), seafood, dairy, and infants obtain carotenoids from human milk
and some infant formula. Carotenoids confer anti-oxidant and anti-inflammatory activities associated with
reduced risk of cancer and cardiovascular diseases. Vitamin A is critical for healthy growth, vision, and immune
function. New evidence suggests roles of carotenoids in early neurodevelopment and metabolic health.
Macular carotenoids confer retinal protection and improved visual function. The conference program
emphasizes scientific, geographical, gender, racial, and cultural diversity more than any other carotenoid
conference. The five-day conference is in a remote location to increase the sense of camaraderie and create
scientific communities, with lasting collaborations and friendships. In addition to premier talks, the conference
has poster sessions from individuals of all career stages, and afternoon free time and communal meals allow
informal networking opportunities with leaders in the field. The conference emphasizes giving early career
scientists the opportunity to present their work. The GRC will be preceded by the 5th edition of the Carotenoids
Gordon Research Seminar (GRS), entirely organized by graduate students and postdocs, and enables them to
present and discuss carotenoid research with their peers. Experienced mentors and trainee moderators
facilitate active participation so that all attendees are engaged participants rather than spectators. Participants
in the Carotenoids GRS have gone on to become major leaders in the carotenoid research field. The
conference seeks to achieve the following aims: Aim 1. To promote cross-cutting discussion of the roles of
carotenoids in human health, with an emphasis on children’s and maternal health, vision, cancer prevention,
and cardiovascular disease prevention. Aim 2. To foster interdisciplinary discussion on progress in crop
biofortification to address human vitamin A deficiency. Aim 3. To advance the careers of women,
underrepresented groups, trainees, and early-career carotenoid scientists by creating an engaging and
inclusive environment. Impact: This interdisciplinary carotenoid conference will fuel innovation and scientists to
understand how carotenoids can support improved human health across the lifespan.

Public health relevance
PROJECT NARRATIVE Carotenoids are antioxidant and pro-vitamin A pigments found in fruits, vegetables, dairy and seafood. This proposal is for an international, interdisciplinary conference on carotenoid biology so that scientists can review the latest findings and develop new hypotheses about how carotenoids can best support pediatric and maternal health, adult health, and prevention of chronic diseases. An emphasis of inclusion of scientists of all backgrounds and career stages will accelerate progress in the field in the near and long-term.